The Nigrotegmental Circuit in an Scn1a+/- Mouse Model of Dravet Syndrome

Project Summary/ Abstract
Although most epilepsy research focuses on neocortical and limbic structures – i.e., typical seizure onset
zones – subcortical regions that significantly regulate the onset and spread of seizures may also be effective
therapeutic targets in epilepsy. The nigrotegmental pathway, consisting of the substantia nigra pars reticulata
(SNr) and its connections to the cholinergic brainstem pedunculopontine nucleus (PPN), plays a crucial role in
the regulation of movement and arousal, and may also represent a promising target for seizure modulation. The
SNr is predominantly composed of GABAergic neurons and exerts powerful control over both forebrain and
midbrain networks through its inhibitory output. This effectively positions the SNr as a central “choke point” within
the basal ganglia and many lines of evidence demonstrate that SNr inhibition produces robust seizure
suppression across multiple epilepsy models. Although activating cholinergic PPN neurons promotes cortical
desynchronization and Rapid Eye Movement (REM) sleep – both of which are considered seizure-protective –
pharmacological manipulation of the PPN during seizures has yielded mixed results, with both pro- and anti-
convulsant effects observed. This highlights the need for further research into the mechanisms responsible for
SNr-mediated seizure suppression and the role of its downstream cellular targets in the PPN during seizures.
The goal of this proposal is to establish the role of the nigrotegmental circuit in seizure initiation and
severity using a well-characterized Scn1a+/- mouse model of Dravet Syndrome, a severe developmental and
epileptic encephalopathy distinguished by pharmaco-resistant and temperature-sensitive seizures. First, we
will activate the SNr→PPN circuit both in slice and in vivo to confirm that SNr activation leads to inhibition of
the PPN. Next, we will record from each region while evoking seizures (with hyperthermia) to determine the
endogenous activity of the SNr and PPN, in addition to the effect of SNr activation on PPN activity during the
peri-ictal period. Finally, we will determine the impact of SNr inhibition and PPN activation on seizure initiation
and severity in Scn1a+/- mice. We will achieve these aims using a combination of techniques – in vivo fiber
photometry, slice and in vivo electrophysiology, circuit-specific opto- and chemogenetics, and seizure-triggered
closed-loop optogenetics.
This approach will allow us to gain cell-type specific knowledge of SNr projections to the PPN and to
manipulate these regions with superior spatial and temporal resolution. The proposed research will meaningfully
advance our understanding of nigrotegmental circuitry and its role in modulating seizures in Dravet Syndrome.
The findings gleaned from this proposal will collectively form the basis for novel, targeted therapies for the
treatment of seizures in Dravet Syndrome and other forms of epilepsy.

Public health relevance
Project Narrative Epilepsy is a debilitating chronic disease estimated to affect more than 3 million people in the United States, resulting in significant health and financial costs. Exploring neuronal circuits that may regulate seizure generation or that can be harnessed for seizure suppression is necessary to identify new targets and approaches for seizure management. In this proposal, we will investigate the nigrotegmental circuit in a preclinical mouse model of epilepsy using cutting-edge techniques for the manipulation and recording of defined neurons with the brain.